EFFICACY OF MEDICAL AND SURGICAL THERAPIES FOR OTITIS MEDIA--OTORRHEA

To determine the efficacy of current methods of management of children with chronic otorrhea through a tympanotomy tube or chronic perforation due to otitis media without cholesteatoma.